First-in-class small molecules for treatment of soft tissue sarcoma and other cancers associated with Agent Orange exposure

VA has recognized that Agent Orange exposure is associated with development of bladder
cancer, chronic B-cell leukemia, Hodgkin’s and non-Hodgkin’s lymphoma, multiple myeloma,
prostate cancer, respiratory cancer, and a subset of soft tissue cancers including fibrosarcoma.
More recently, burn pit exposure has also been implicated in development of several cancers including
fibrosarcoma. Patients with advanced cases of fibrosarcoma have poor long-term survival because of
resistance that cancer cells develop to chemo, radiation, and biologic therapies. An effective solution is
to target multiple components in an essential cancer growth and metastasis pathway. Hypoxia Inducible
Factors (HIF) are transcription factors that are activated by hypoxia and other environmental stresses
present in solid tumors. The enzyme acyl-CoA synthetase short chain family member 2 (Acss2) also
responds to oxygen or glucose deprivation. Acss2 and HIF-2 are independent components of a
signaling axis that is usurped by cancer cells to promote tumor growth and metastasis.
Acss2/HIF-2 signaling favors cancer spread, whereas depleting Acss2 or HIF-2 reduces growth
and metastasis of fibrosarcoma-derived tumors in mice. Not surprisingly, Acss2 and HIF-2 are
over-expressed in cancers including soft tissue tumors. Because of its dual role in cytosolic
intermediary metabolism and nuclear signaling, Acss2 is considered a high value therapeutic target.
Indeed, reducing Acss2 levels blunts cancer growth in cell and mouse models including fibrosarcoma.
Although usually very stable, select mutations in the Acss2 carboxy terminal hinge region dramatically
shorten Acss2 half-life, which is due to unmasking of potent protein destabilizing elements (PDE) in
Acss2 that are normally hidden within an intra-molecular cage. When these PDE in Acss2 are
unmasked, the otherwise stable Acss2 protein is rapidly eliminated. Instability of Acss2 has functional
consequences as fibrosarcoma-derived cells expressing unstable Acss2 protein have markedly
reduced tumor growth and metastases in mice with flank tumors derived from these cells.
Our goal is to develop first-in-class drugs to treat fibrosarcoma and other cancers associated
with Agent Orange and burn pit exposure. In this proposal, we will identify small molecules that
unmask PDE in Acss2 and induce its elimination from cancer cells. To identify inducers of Acss2
degradation, we will screen a large chemical diversity library in collaboration with the Columbia
Genome Center High-Throughput Screening Facility using stable cell lines expressing enzymatic
(primary screen) or orthogonal fluorescent (secondary screen) reporters fused with portions of stable or
unstable Acss2 proteins. We will use cell-based assays to assess the impact of hits from this screen on
Acss2-specific features including protein levels, lipid synthesis, and cancer cell properties. Select
candidates will be further developed into compounds that ultimately will be tested for their ability to
reduce growth and metastasis of fibrosarcoma flank tumors in mice. Our overall objective is to use
these novel small molecule drugs as stand-alone or supplemental treatment for Veterans with
advanced stage fibrosarcoma and other cancers associated with Agent Orange and burn pit exposure.

Public health relevance
VA has recognized that Agent Orange, and more recently burn pit, exposure is associated with development of several malignancies including the most common soft tissue cancer, fibrosarcoma. Patients with advanced cases of fibrosarcoma are resistant to chemo, radiation, and biologic therapies, which results in poor long-term survival. An effective solution is to target essential cancer growth and metastasis pathways. This Validation study will screen for novel small molecules that induce degradation of a therapeutic target protein Acss2, a lynchpin protein in a key signaling pathway that promotes cancer growth and metastasis. The proposed studies will identify hits in a primary screen, validate hits in a secondary screen, and evaluate their effectiveness on endogenous Acss2 in a tertiary screen. Candidates that meet pre-established criteria will be designated lead candidates and will undergo further optimization in future efforts. The Potential Impact on Veterans Health Care gained from these studies is development of novel first-in-class drugs for treatment of advanced stage fibrosarcoma in Veterans.